Programmed cell death and cytomegalovirus retinitis pathogenesis

Program Director/Principal Investigator (Last, First, Middle): Dix, Richard D
Project Summary
Programmed cell death (PCD) operates during innate immunity to eliminate virus-infected cells and regulate
infection-associated inflammation during virus invasion. Little information is available regarding the precise
contributions of PCD toward the pathogenesis of retinal diseases of virus origin, especially those caused by
herpesviruses including AIDS-related human cytomegalovirus (HCMV) retinitis. A critical barrier to progress
in advancing our ability to diagnose, prevent, and/or treat herpesvirus retinal diseases has been a lack of
information on the possible contributions of different forms of PCD toward onset and development of these
virus-induced retinal diseases including AIDS-related HCMV retinitis. Our goal is to address this knowledge
deficit and the critical barrier to progress by obtaining new information needed to define the relative individual
and collective roles of apoptosis, necroptosis, and pyroptosis during onset and development of this sight-
threatening eye disease using an established mouse model of murine cytomegalovirus (MCMV) retinitis in
mice with retrovirus-induced immunosuppression (MAIDS). Our central hypothesis is that apoptosis,
necroptosis, and pyroptosis conspire via different mechanisms to contribute to the severe retinal tissue
destruction during MAIDS-related MCMV retinitis pathogenesis. Our objectives are to use the MAIDS model
of MCMV retinitis to (1) obtain the information needed to understand the precise contributions and begin to
understand the mechanisms by which these PCD pathways contribute to retinal tissue destruction and loss of
function, (2) explore the mechanisms by which these PCD pathways stimulate inflammation within retinal
tissues during retinal disease onset and development, and (3) establish that PCD inhibitors represent a new
therapeutic approach for management of cytomegalovirus retinal disease. These objectives will be met through
successful completion of three Specific Aims: (1) test the hypothesis that multiple PCD pathways contribute to
retinal tissue destruction during MAIDS-related MCMV retinitis pathogenesis, (2) test the hypothesis that PCD-
initiated inflammation plays a critical role in development of retinal tissue destruction during MAIDS-related
MCMV retinitis pathogenesis, and (3) test the hypothesis that PCD inhibitors will alter the onset and
progression of MAIDS-related MCMV retinitis.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Dix, Richard D Project Narrative The proposed project is relevant to public health because its performance will demonstrate for the first time that intraocular stimulation of multiple cell death pathways through different mechanisms contribute to the severe retinal disease pathology and loss of function that develops during pathogenesis of AIDS-related HCMV retinitis. The project is relevant to the NEI mission because its performance could lead to new therapeutic approaches to lessen vision loss and blindness associated with HCMV retinitis during AIDS and other forms of immunosuppression through use of cell death pathways inhibitors. This novel therapeutic approach could extend to other retinal diseases of herpesvirus origin in immunologically normal persons. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page